Small Talk: Administrative Supplement for Tackling Acquisition of Language in Kids (TALK) Initiative

PROJECT SUMMARY/ABSTRACT
Administrative Supplement for Tackling Acquisition of Language in Kids (TALK) Initiative
The goal of this study is to identify prevalence and characteristics of late language emergence (LLE)
among young children (~24 to 27 months of age) reared in low-income homes, and to determine how the
conditions of poverty contribute to LLE status among these vulnerable children. The study uses data collected
across the first five time-points of a parent grant that is designed to address disparities in the rate of
developmental language disorder (DLD) among young children, with low-income children disproportionately
affected (Norbury et al., 2017). The long-term objective is to identify pathways through which early family
contexts and the conditions of poverty disrupt early language trajectories among low-income children and
contribute to heightened rates of LLE (the focus of the TALK supplement) and DLD. The proposed longitudinal
study addresses three specific aims specific to an existing longitudinal sample of 220 low-SES 2-year-old
children: (1) to identify the prevalence of LLE and the theorized domains in the Family Stress Model that
differentiate children with LLE from those without LLE; (2) to examine early language trajectories from ~6
months to ~27 months for those with LLE and those without LLE; and (3) to identify the pathways through
which the ecology of poverty disrupts early language trajectories and contributes to LLE. Specifically, we will
evaluate the Family Stress Model to identify the relations among five domains representing salient conditions
of poverty (economic hardship, economic pressure, parent psychological distress, interpersonal relationship
problems, and disrupted parenting) and their mediating and moderating roles in disrupting children's early
language trajectories and leading to LLE status. In the parent study, measurements were collected twice
annually to comprehensively map family processes and experiences, caregiver-child interaction quality,
caregiver stress and stress physiology, child stress physiology, and children's linguistic trajectories. With this
supplement, we are able to embed a focus on LLE and the influence of poverty conditions on young children's
susceptibility for LLE, a group for whom LLE exceeds normative prevalence estimates in unselected
population-based studies.

Public health relevance
PROJECT NARRATIVE Administrative Supplement for Tackling Acquisition of Language in Kids (TALK) Initiative Late language emergence (LLE) disproportionately affects young children raised in low-income households. It can signal vulnerability for developmental language disorder, the most common developmental disability affecting young children, with serious consequences for young children's overall development and educational achievement and for later socioeconomic and health disparities. The goal of this study is to identify the ways in which the conditions of poverty contribute to LLE among young, low-income children, and to examine the early linguistic trajectories for those affected and not affected.